Gene Network Perturbations in Alcohol Dependence - A Systems BiologyApproach

This is the first competitive renewal of an innovative project at the interface of computational
analysis of gene network regulation and behavioral pharmacology aimed at identifying and exploring
new testable mechanistic and therapeutic hypotheses on the progression to excessive drinking and
alcohol dependence, resilience and vulnerability to developing alcohol use disorder (AUD). The
ultimate goal is to reveal and validate new and more effective therapeutic targets for AUD.
Results of the current (first) funding period demonstrate that broad regulators of alcohol actions of
phenotypic significance can be identified with the present experimental-computational systems
biology strategies; which contributed to the identification of 3 candidate drugs for repositioning for
AUD that are currently advancing toward clinical testing. Building on these results, in Specific Aim 1
of the proposed second funding period we aim to understand the molecular bases of the interactions
of alcohol with the gene regulatory networks at a greater level of resolution by bringing to bear gene
expression profiling of neurons, astrocytes, microglia and oligodendrocytes purified by fluorescence-
activated cell sorting (FACS) from key brain regions of rats with histories of either moderate or
excessive (escalated) alcohol self-administration. The sub-hypothesis under testing with this
approach is that conducting gene regulation analyses at the cellular level of resolution will allow us to
identify key cell type-specific and -common gene network dysregulations, and may point to previously
unrecognized regulatory mechanisms of therapeutic potential. Specific Aim 2 will test the sub-
hypothesis that the master regulator genes (MRs) governing the expression of specific gene
signatures associated with the effects of alcohol have specific roles in motivation for alcohol and can
serve as candidate druggable targets. In particular, studies in Specific Aim 2 will explore selected
mechanistic hypotheses derived from gene regulatory analyses conducted in the current funding
period and under the proposed Specific Aim 1 for their role in phenotypes of excessive alcohol
drinking using computational, biochemical, behavioral and morphological strategies.
Altogether, the present proposal will explore the transcriptional network dysregulations at the cell-
type level of analysis associated with moderate and excessive alcohol intake to identify new
mechanistic hypotheses on the neurobiological bases of excessive alcohol drinking that are expected
to lead to the identification of novel therapeutic targets for AUD.

Public health relevance
Narrative. We hypothesize that the master regulator genes (MRs) governing the expression of specific gene signatures associated with the effects of alcohol and alcohol dependence are crucial in the reinforcing effects of alcohol, resilience and vulnerability to excessive alcohol drinking and relapse after cessation, and can point to novel and more effective therapeutic targets for alcohol use disorder (AUD). To test this overarching hypothesis, innovative systems biology strategies implemented in the current (first) funding period will be used to dissect the gene regulatory networks involved in the effects of moderate and excessive alcohol drinking through gene expression profiling of neuronal and glia cellular elements. Ultimately, the proposed experimental- computational approach will result in a better understanding of the molecular mechanisms that orchestrate the transition from moderate to excessive alcohol drinking and will highlight new and more effective therapeutic targets for AUD.